Formation and Regulation of Meiotic Crossovers

PROJECT SUMMARY
Diploid organisms, including humans, create haploid gametes for sexual reproduction through the specialized
cell division program of meiosis. For meiosis to occur successfully, Crossover (CO) repair of DNA double-
strand breaks (DSBs) is essential, as it creates temporary connections between homologous chromosome
pairs that promote orderly homolog segregation at the first division. Failure to form COs results in aneuploidy,
the leading cause of miscarriage and birth defects in humans. Yet, CO formation relies on the creation of
DSBs, which pose a significant danger to genomic integrity. Meiotic cells must therefore balance the risks
imposed by DSBs with the requirement for COs to promote orderly chromosome segregation. Further, CO
formation is highly limited and constrained: In many organisms, the majority of DSBs are repaired as non-COs
(which restore genomic integrity but do not connect homologous chromosomes), whereas CO recombination
occurs at only a single DSB site per chromosome (or per chromosome arm). This restriction of CO formation
necessitates that each site selected to become a CO must reliably mature as a CO. The paradox of requiring,
yet limiting, CO recombination leads to several major outstanding questions: How are a subset of DSBs
selected to become COs? What are the mechanisms that operate to ensure and limit CO formation? How is
robustness conferred to the process of CO maturation? The proposed research will investigate the
mechanisms that promote and ensure reliable formation of meiotic COs, exploiting genetic and cytological
features of the C. elegans experimental system that make it especially amenable to addressing these issues.
The strategy will focus on COSA-2 (CO-Site Associated), a newly-discovered intrinsically-disordered protein
that I identified as a critical component of the CO machinery. COSA-2 exhibits striking localization to CO-
designated recombination sites and is required for the retention/accumulation of additional CO-promoting
factors at these sites. My preliminary data have led to the hypothesis that COSA-2 promotes CO formation by
acting as a hub protein to concentrate CO-promoting factors, stabilize CO-site architecture, and promote
formation of a protected spatial compartment to ensure CO-specific repair of DSBs. I will test this hypothesis
by: (1) using innovative cytological methodologies and super-resolution microscopy to probe interrelationships
between COSA-2 and known CO factors, CO-site architecture, and meiosis-specific chromosome structures;
(2) identifying COSA-2 protein partners and features of the COSA-2 protein that contribute to its CO-promoting
activity, and (3) using temporally-controlled protein degradation and ectopic recruitment assays to test the
mechanistic role of COSA-2 in CO maturation at natural CO sites and to evaluate whether COSA-2 can drive
formation of CO-site-like compartments and/or stimulate CO-specific repair. Experiments in this proposal will
illuminate fundamental mechanisms that promote reliable formation of the COs needed to direct orderly
chromosome segregation and ensure the faithful inheritance of genomes.

Public health relevance
PROJECT NARRATIVE The proposed research will elucidate fundamental mechanisms that ensure the faithful inheritance of chromosomes during meiosis, the specialized cell division program that produces sperm and eggs. Errors in the inheritance of chromosomes are the primary known cause of miscarriage and birth defects and are also a major factor contributing to the development and progression of many cancers, making the study of meiosis informative for human health at multiple levels. My approach will focus on a newly discovered component of the meiotic machinery that provides an exceptional opportunity to investigate the formation and regulation of meiotic crossovers, which are needed to direct faithful chromosome segregation during meiosis.